Ultra Wideband Fall Detection and Prediction Solution for People Living with Dementia

Abstract:
Older adults with cognitive impairment experience an increased risk of falling than those without cognitive
impairment. Unfortunately detecting falls or assessing fall risk among persons living with dementia (PLWD) can
be challenging due to difficulties in collecting self-reported information or communicating functional test
instructions. The proposed project will develop and test an automated fall detection system using Ultra
Wideband (UWB) band technology. The advantage of UWB, along with well-established accelerometer and
gyroscope technology, is that it produces a more precise resolution (5-10cm) than Bluetooth (1-5m) or Wi-Fi
(5-10m). UWB’s real-time location tracking capacity can enhance fall detection accuracy and context, and with
a call alert system reduce response time. In addition, the proposed system will collect rich mobility data to
enable the detection of mobility-related fall risk (e.g., changes in gait and balance). Thus, if successful, the
proposed system is expected to simplify and enhance mobility-based fall risk, fall detection, and quickly send
alerts for PLWD. Building on prior work to develop a fall detection system prototype, this fast-track application
proposes two phases moving from lab studies to real-world applications. Phase 1 will test the ability of
Theora® 360, a novel fall detection system, to detect simulated falls in a laboratory setting, whether sensor
location makes a difference in fall detection accuracy and initial user feedback. Milestones to proceed to the
next phase are 90% sensitivity and 90% specificity in fall detection in a laboratory setting and codification of
protocols, preliminary algorithms, and data platforms for 3D location processing, motion sensing/
categorization, and fall detection. Phase 2 will assess Theora® 360’s ability to detect mobility-based falls
among PLWD and to predict changes in fall risk over time in 60 care-recipient-caregiver dyads living at home.
Using a previously established neural network, changes in overall mobility, gait characteristics, and daily
routines will be observed to develop algorithms for activity modeling and risk profiling. Feedback on technology
use and user satisfaction including recommendations for solution improvement will be obtained through
technology records, usability surveys, and interviews at the end of the study. Thus, the study represents a
mixed model approach with objective sensor data on a 24/7 basis; functional assessments, survey data
assessing sociodemographic, care, and psychosocial factors collected five times throughout the study, and
qualitative usability data collected toward the end of the study to better understand the complexity of assessing
fall risks and commercialization potential of this new technology among PLWD and their caregivers. Envisioned
as a corporate-academic partnership between Clairvoyant Networks and Texas A&M University Center for
Community Health and Aging, this proposal draws upon expertise in business, aging, dementia, public health,
clinical sciences, computer sciences, and engineering, and will benefit from the input of a distinguished
advisory group.

Public health relevance
Project Narrative Falls are a major public health concern, especially for people living with dementia; yet precise and practical fall detection systems are lacking. This project will conduct both lab and field studies (n=168 participants) to assess the accuracy of Theora® 360, an innovative automated fall detection system that uses Ultra Wideband technology combined with motion sensors to detect falls and assess mobility changes, fall risk, and fall context among community-dwelling people living with dementia (PLWD). Usability studies will also be built in to help ensure that system components are user-friendly. Successful completion can provide a valuable resource for PLWD to pursue aging in place and for caregivers to advance care while reducing caregiving burdens.